Privacy-Aware Federated Learning for Breast Cancer Risk Assessment

ABSTRACT:
Federated learning (FL) has gained a lot of attention recently, as it enables analyses of data from numerous
collaborating sites without the need to share data, i.e., each collaborator’s data are always retained within their
site. FL is advantageous as it can: 1) overcome cultural/ownership, privacy, and regulatory concerns (since data
never leave the local site), 2) provide access to restricted data, 3) allow the collection of meaningful amounts of
data for analyses of rare diseases, and 4) address health disparities and inequities. Thus, FL can be noted as a
novel paradigm for multi-site collaborations, enabling access to ample and importantly diverse data, essential to
developing robust models generalizable in unseen data. To this end, we have developed the Federated Tumor
Segmentation (FeTS) platform and the Open Federated Learning (OpenFL) library, as open-source tools with a
commercially friendly license that have facilitated a) the largest to-date real-world federation, involving 3D brain
tumor MRI data from 71 sites across 6 continents, and b) the very first computational challenge in FL, forming
the first benchmarking environment and dataset in the field. This FeTS-OpenFL infrastructure has further been
used to c) identify tumor-infiltrating lymphocytes in histopathology images and d) segment dense tissue in 2D
digital mammography (DM), highlighting its generalizability in different imaging and disease types. Building upon
our successful FeTS-OpenFL infrastructure, we propose to enhance its functionality with new developments on
privacy-aware FL towards classification workloads and evaluate it on a first-of-its-kind use case on breast cancer
(BC) risk assessment. BC is the most diagnosed cancer in the US, the 2nd leading cause of death from cancer
in women, and screening is performed routinely with 2D digital mammography (DM) for women in their 40s-50s.
However, DM yields a lot of false positives and unnecessary subsequent procedures. To alleviate these issues,
3D Digital Breast Tomosynthesis (DBT) has been developed and increasingly replacing DM. Our group has
developed novel volumetric breast density (VBD) measures from DBT scans. Building upon our team’s collective
pioneering work in FL and BC risk assessment, in this proposal we focus on developing a trustworthy, zero-code
principle FL framework for training AI-based classification models and built-in functionality to i) generate realistic
synthetic data, matching local population characteristics, for data augmentation & privacy preservation, and ii)
automatically determine quantitative & interpretable settings of optimal privacy preservation. We will use this
framework to perform the largest to-date evaluation of training deep-learning models for BC risk assessment
using DBT VBD measures and other established risk factors while leveraging multi-site, ethnically diverse data
of women undergoing BC screening. We will also disseminate resources via distribution of source code,
deployment to collaborating sites, and organization of training activities. Our overarching goal is an easy-to-use
translatable trustworthy FL framework, lowering the barrier for under-served populations to participate in large-
scale FL studies, and paving the way to address health disparities, towards accelerating discovery healthcare.

Public health relevance
NARRATIVE: Successful completion of this proposal will lead to a trustworthy zero-code federated learning (FL) software framework, lowering the barrier to leverage data from under-served populations in large-scale, secure, de- centralized multi-institutional collaborations, without the need to share patient data, thereby i) overcoming legal, privacy, and data-ownership concerns, and ii) paving the way to address health disparities and inequities, towards accelerating discovery in healthcare. This framework will further support the clinical impact and lifecycle of FL studies by offering a) pre-trained breast cancer risk assessment models leveraging multi-site, ethnically diverse data of women undergoing breast screening, and functionality specific to b) improving these pre-trained models, by including additional geographically diverse sites, c) data synthesis for data augmentation & privacy preservation, based on realistic synthetic data matching each site’s local patient population characteristics, and d) an automated mechanism for quantitative & interpretable determination of optimal privacy preservation.